Administrative Core

This will be a U19 research program under the guidance of the Director Samuel I. Miller and the Administrative Core Leader John Kemner. Dr. Miller will have the primary responsibility for coordinating the projects and Cores within the overall Program. The Administrative Core of the center will provide strategic planning, oversight and management of the program and its resources. The specific aims of the Administrative Core are to: 1) Organize and manage the resources of the center, 2) Organize meetings and facilitate communication between components of the program, 3) Facilitate local, regional, national, and international collaborations, 4) Prepare reports and measure outcomes, and 5) Manage intellectual property and regulatory issues.

Public health relevance
An administrative core will be established to provide scientific, programmatic, and business support for the Center to study the "Function of Unknown Genes of Acinetobacter baumanii."